Disparities in developmental-behavioral diagnoses in Hispanic immigrant children: role of parent concern and screening

PROJECT SUMMARY
Developmental-behavioral disabilities are present in nearly 1 in 5 children in the United States and are among
the most common concerns parents discuss at primary care visits. Autism Spectrum Disorder (ASD) is one of
these conditions, which is characterized by differences in social and sensory processing. While ASD occurs in
approximately 1 in 53 children, racial-ethnic groups are diagnosed at different rates. White children have the
highest prevalence (2.65%), and Hispanic children are least likely to be diagnosed (1.94%). Moreover, 0.5% of
Spanish-speaking children and 0.3% of children with two foreign-born parents have a documented diagnosis.
This disparity is similar for other conditions and has a profound impact in access to treatment. Screening in
primary care pediatrics is one mechanism for early identification of child risk behaviors; however, this process
does not facilitate diagnosis as expected for Hispanic children. This is likely a function of the interplay between
parental report of behaviors, validity of screening instruments in this population and provider diagnostic
practices. While disparities for Hispanic immigrants and provider’s views are well documented, the
mechanisms underpinning differences in diagnosis are not well understood. Additionally, parental perspectives
on child’s behavior and diagnosis are insufficiently represented. Rich data on socioecological factors in the
context of immigration and child health outcomes are not readily available and relationships are subsequently
underexplored. Profound challenges related to resettlement in the United States contribute to risk for
developmental-behavioral disorders. Apart from this direct relationship, these immigration-related factors
influence how parent’s behavioral concerns develop and are represented on clinical screening instruments. For
example, discrimination can increase risk for behavioral disorders in children while simultaneously impacting
parent’s perception of these behaviors. This will subsequently affect how well screening instruments capture
parent concerns. This study will quantitatively assess how these relationships contribute to diagnostic
disparities. The study uses an adaptation of the Trajectory Model for Immigrant/Refugee Health to model
relationships between socioecological factors, parent concern for behavior, screening results and clinical
diagnosis. This conceptual orientation emphasizes structural contributions to inequalities while providing
evidence to support improvements in clinical care for this population. This secondary analysis uses a
community sample collected by PolicyLab Research Center at The Children’s Hospital of Philadelphia. Aim 1
will determine the relationship between socioecological clusters and parent reported child concerns. Aim 2 will
assess concordance between parental concern and clinical screening results. Aim 3 will test the model
proposing parental concern and screening as mediators of socioecological predictors of clinical diagnosis.
Analytical strategies include cluster analysis, regression, and structural equation modeling. This study will
provide foundational evidence to reduce diagnostic disparities for Hispanic immigrant children.

Public health relevance
PROJECT NARRATIVE Disparities in diagnosis for developmental-behavioral conditions for Hispanic immigrant children are pervasive yet poorly understood. This study will examine the relationships between socioecological factors related to immigration, parental concern for child behavior and screening instruments in the diagnostic process. These results will add to the literature by describing the mechanisms that drive child health disparities with the goal of developing interventions to improve clinical care.